Neural Control of Metabolic Physiology and Diseases

DESCRIPTION (provided by applicant): Support is requested for a Keystone Symposia meeting entitled Neural Control of Metabolic Physiology and Diseases, organized by Dongsheng Cai and Martin G. Myers, Jr. The meeting will be held in Snowbird, Utah from April 12-17, 2015. The central nervous system, including the hypothalamus in particular, is important for the control of energy balance and metabolic homeostasis. Current research continues to generate important new understanding of the molecular, cellular, and neural mechanisms underlying this control. From a disease perspective, dysregulation of these processes appears to be crucial for the development and progression of the metabolic syndrome - including obesity, glucose intolerance/diabetes and hypertension - as well as the pathogenesis associated with aging. Recent research has begun to define and characterize the neural pathways involved in these processes. This Keystone Symposia meeting will bring together breaking research advances from both the basic science and translational realms, including new knowledge of neural circuits, plasticity and signaling, as well as insights into roles for hypothalamic/brain pathways in disease development. Also importantly, several new areas will be addressed, including state-of-art technologies for neuroscience research, adult neural stem cells, neural degeneration, microglia, aging, and related alterations of metabolic resilience.

Public health relevance
PUBLIC HEALTH RELEVANCE: Diabetes, obesity, and related metabolic diseases represent major causes of morbidity and mortality in modern society, and contribute tens of billions of dollars to the cost of health care each year. The brain controls major parameters related to obesity (the decision to eat; the control of energy expenditure), and alterations in the neural systems that control metabolism may contribute to the pathogenesis of diabetes and metabolic diseases, much as the neural systems that control body weight contribute to obesity pathogenesis. To understand how the brain controls metabolism and how such processes may be targeted for therapy, it will be crucial to unite the multiple disparate scientific disciplines hat focus on the brain, behavior, metabolism, and therapeutics. The goal of this unique meeting focused on the Neural control of Metabolic Physiology and Diseases is exactly that: to bring together scientists that study neural circuits and/or the control of neural cell biology with those who focus on metabolic physiology, relevant behaviors, and those who seek to understand and develop novel therapeutic modalities.